Longitudinal multi-modality imaging in non-fluent/agrammatic primary progressive aphasia

PROJECT SUMMARY
The non-fluent/agrammatic variant of primary progressive aphasia (nfvPPA) is a neurodegenerative disorder
defined by the presence of agrammatic aphasia and/or apraxia of speech that commonly results from a 4-
repeat tauopathy. During the previous 2 cycles of the R01 we used neuroimaging to characterize the patterns
of neurodegeneration and structural and functional breakdowns in connectivity associated with nfvPPA.
However, little is known about how these brain changes are related to, or driven by, underlying biological
processes. Two important biological mechanisms relevant to nfvPPA are deposition of the protein tau and
neuroinflammation. In the 2nd cycle of the R01 we assessed tau deposition in vivo using PET. In the 3rd cycle
we will focus on assessing the role of neuroinflammation and other biological processes. The first aim
of the grant is to characterize the patterns of neuroinflammation in the brain using PET imaging with the 3rd
generation ligand 11C-ER176 and determine whether neuroinflammation changes over time and is associated
with clinical disease severity. The second aim is to determine whether biomarkers of pathological processes
measured from blood plasma, including neurofilament light chain, plasma glial fibrillary acidic protein, tau, and
inflammation biomarkers, are abnormal in nfvPPA. We will also assess whether these biomarkers change over
time and are associated with clinical disease severity. These first two aims will determine whether
neuroinflammation PET and blood plasma biomarkers are useful disease biomarkers in nfvPPA, and we will
determine whether these measures could be useful prognostic markers of future clinical decline. Our third
objective is to build upon knowledge gained from the first 2 cycles and determine how structural and functional
abnormalities in the brain, measured using structural MRI, diffusion tractography and resting state fMRI, are
related to neuroinflammation PET and blood plasma biomarkers. This aim will help model the degree to which
these biological processes relate to other more established breakdowns in brain structure and function. To
accomplish these aims we will recruit 50 patients with nfvPPA, and each participant will undergo three serial
assessments one year apart. At each assessment, patients will have a neurological and speech-language
assessment, 11C-ER176 neuroinflammation PET and a 3T magnetic resonance imaging scan that will include
resting-state functional MRI and diffusion tensor imaging sequences. A blood sample will be collected from all
patients at both visits. Blood samples were also collected in the 2nd cycle of the R01 and hence blood plasma
biomarkers will be measured in 100 nfvPPA patients. We will also recruit 50 cognitively normal healthy controls
who will undergo identical neuroimaging and provide a blood sample. This renewal is highly significant as
results gained will be critical to understand the biology of nfvPPA and mechanisms of disease spread.
Furthermore, this work may also help provide potential mechanistic treatment targets for nfvPPA and establish
disease biomarkers for prognosis and for future research studies and clinical trials in patients with nfvPPA.

Public health relevance
PROJECT NARRATIVE This study will use novel analysis techniques to investigate biological processes in the brain that are related to disease progression in patients with the non-fluent/agrammatic variant of primary progressive aphasia. We will measure brain neuroinflammation using neuroimaging, as well as biomarkers of neuroinflammation and neurodegeneration from blood samples, and determine how these biological processes relate to clinical disease progression and structural and functional abnormalities in the brain. The study will improve our understanding of disease progression in these patients, provide new biomarkers of disease, and lead to better targeted future treatments.